Understanding Low-Value Veteran Care with Natural Experiments

Background: Low-value medical services are common and costly. Veterans often receive services that offer
little or no clinical benefit while generating costs and unnecessary risks. Gaps in research have hindered
effective policies to address low-value Veteran care. First, the causes of low-value service use are uncertain.
For example, through the VA Community Care program (VACC), Veterans are treated by non-VA clinicians
who face few incentives to avoid unnecessary tests and procedures. However, it is unclear whether VACC has
increased Veterans’ risk of receiving low-value services. Our research has shown an association between
greater use of VACC and increased rates of low-value care. Rigorous quasi-experimental research could
confirm whether this association is causal, guiding appropriate policy responses. Second, policies addressing
low-value care have been hindered by a lack of evidence on what constitutes low-value care and how to
translate evidence into effective clinical decision-making. To address these research gaps, first, I will test
whether VACC under Choice/MISSION has increased low-value care. Second, I will study strategies to
address low-value care via evidence development and evidence translation.
Significance/Impact: Addressing low-value health care use is of crucial importance to Veterans, aligning with
multiple dimensions of HSR&D priority domains including priority research areas (health care value, quality and
safety of health care), priority HSR methods (advancing HSR methods in areas that cut across conditions or
care settings), and priority policy/legislative areas (MISSION Act).
Innovation: This research applies innovative methods to novel research questions. The quantitative methods
have wide potential applications across VA HSR, though they have been rarely applied in this setting.
Specific Aims: This Career Development Award (CDA) would support the following research aims:
Aim 1 Quantify the effect of VACC under Choice/MISSION on Veterans’ low-value service use and spending.
Aim 2a Convene an expert panel to identify and prioritize “gray zone” services ideal for evidence development.
Aim 2b Conduct focus groups to identify barriers and facilitators to translating new evidence on service value
into high-value practices
Methodology: Aim 1: Using 33 measures of low-value services applied to national clinical data, we will test the
effect of outpatient VACC on low-value service use and spending. A regression discontinuity (RD) analysis will
examine a natural experiment that arose because VACC eligibility can differ for otherwise similar Veterans who
live slightly different distances from VA facilities. Machine learning covariate selection techniques will optimize
statistical power. Aim 2a: Via an expert consensus building process, clinicians, researchers and Veterans will
prioritize “gray zone” services, which have unclear value, for evidence development. Services will be prioritized
based on incidence among Veterans, expected costs/harms, and analytical tractability for RD analysis in VA
data. Aim 2b: We will conduct focus groups with clinical and health system leaders as well as Veterans;
drawing on a conceptual model of health care value, we will identify barriers and facilitators to translating new
evidence on low-value services into high-value practices. Complementary training aims in qualitative methods,
machine learning, and learning health system competencies will support the research aims.
Next Steps/Implementation: This work has the support of the VA Office of Analytics and Performance
Integration and VA Office of Community Care, operational partners whose efforts to detect and address low-
value care will be enhanced by this research. I will collaborate with the VA Office of Community Care to assess
how Aim 1 results will inform their efforts to discourage low-value care in VACC. I will submit one IIR proposal
evaluating VA efforts to employ utilization management strategies in VACC. I will submit a second IIR proposal
to quantify the value of high-priority gray zone services identified in Aim 2.

Public health relevance
Veterans, like other patient populations, often receive low-value health care services whose costs or harms exceed their benefits. Our work will address two key knowledge gaps on this topic. First, while low-value services are common, it is not clear why Veterans receive them. We will test whether the Choice/MISSION Act reforms, which increased Veterans’ access to non-VA clinicians, increased Veterans’ risk of receiving low- value services. Second, we lack high-quality evidence on what constitutes low-value care as well as what strategies are effective for translating evidence into clinical decision-making. We will investigate strategies to address low-value care via evidence development and evidence translation. Thus, our research will elucidate the causes of, and potential solutions to, low-value health care. This work directly aligns with the VA mission of ensuring high-value Veteran health care. It will provide VA with critical information to prioritize and implement policies with the goal of reducing low-value Veteran care in VA and non-VA settings.